A Centralized Clinical Research Tool for Accelerating the Development, Evaluation, and Dissemination of Expert-Developed, Evidence-Based, and AI-Enhanced Digital Mental Health Therapies

PROJECT SUMMARY/ABSTRACT
Mental health burden in the US is substantial [1-3], with millions of people lacking access to effective and timely
mental health care [4-6]. Although digital mental health technologies hold great promise for addressing this crisis
[7-9], widescale adoption of digital health has faced significant challenges, including the high costs of developing
therapy apps, complex and expensive regulatory barriers, fragmented user adoption, and a lack of trust among
providers and patients [10-12]. Colliga addresses barriers to digital mental health adoption via a centralized “hub”
that supports the fast and inexpensive development, testing, and dissemination of evidence-based, AI-enhanced
mental health apps. Colliga provides a comprehensive technological ecosystem where scientists, providers, and
patients can collaborate seamlessly. Colliga’s integrated platform design enables scientists to develop, test, and
publish custom AI-enhanced mental health therapy apps on the App and Google Play stores instantly and at no
cost to them using our point-and-click web tool. Providers and patients benefit from easy-to-access, curated, and
scientifically validated mental health apps tailored to patient needs, thus enhancing clinical decision-making and
expanding treatment options. Colliga’s goal is to democratize access to high-quality and evidence-based mental
health care by fostering wider adoption and sustainable use of effective digital therapies. Our parent Fast-Track
SBIR award (R44MH123368, Ahle, Timmons, Comer) funded the development of the platform system, adaptive
AI sensing technology, and a proof-of-concept randomized clinical trial for the first test case app on the platform,
the TIES Parenting program, a transdiagnostic app for kids 6-9 years and their parents. Promising preliminary
results from this randomized clinical trial position Colliga for further expansion through collaboration with scientist
partners to launch follow-on programs across key mental health domains to expand Colliga’s offerings and use
cases. Commercialization Readiness Pilot Program funding is needed to transition this promising and innovative
technology from the research and development phase to commercial readiness by enhancing the technological
infrastructure to ensure reliability and security for clinical deployment at scale (Aim 1), implementing final feature
enhancements needed for clinical usability, adoption, and engagement (Aim 2), and executing commercialization
and regulatory strategic plans in critical domains (Aim 3). These commercialization activities will position Colliga
as a scalable and sustainable digital mental health platform capable of reaching diverse populations and meeting
clinical standards for widespread adoption. Our innovative approach combines user-friendly development tools,
a secure and scalable platform “hub,” and customizable AI technology to set new standards for ethical, inclusive,
and evidence-based digital mental health solutions for all. By streamlining the path from research to real-world
clinical application, Colliga accelerates scientific advancements, broadens access to effective therapy apps, and
empowers scientists and mental health providers to deliver high-quality care. These efforts aim to improve mental
health outcomes for all people, with the goal of creating a lasting and positive impact on public mental health.

Public health relevance
PROJECT NARRATIVE This project addresses critical gaps in mental health care through an AI-enhanced digital platform “hub” designed to make evidence-based mental health interventions accessible, scalable, and clinically relevant. By facilitating the rapid development, testing, and publication of adaptive and personalized digital therapies, Colliga empowers scientists and providers to meet public health needs efficiently and effectively. This platform has the potential to drive scientific innovations and improve clinical outcomes, benefiting public mental health on a population level.